Gluconeogenesis and Glycogenolysis - Role and Regulation

Project Summary/Abstract
The proposed studies will clarify the mechanisms by which glucose metabolism is dysregulated following
consumption of a diet high in fat and fructose (HFHF; i.e. “Western diet”). Studies will be carried out in normal
and diet-induced glucose intolerant dogs. The canine model is unique in that it allows infusion into the hepatic
portal vein (e.g., insulin, glucagon, glucose, amino acids, etc.), as happens with feeding, something that is not
possible in the human or rodent. In the transition from feeding to fasting the liver switches from glucose
production to uptake (HGP→HGU), a process critical to the maintenance of normal glucose tolerance. Hepatic
glucose metabolism is regulated by three principal signals: insulin, glucose, and neural input (portal glucose
signal [PGS]). The latter occurs when the glucose concentration in the hepatic portal vein is greater than in
arterial blood, as occurs when glucose is absorbed from the gut. Consuming a HFHF diet severely impairs
HGU. Although this is due, in part, to liver insulin resistance, we recently found that hepatic glucose resistance
plays an even greater role. In this proposal we: 1) explore the impact of the route of insulin delivery on the
compromised liver. Patients with diabetes are normally treated with subcutaneous insulin injection, which
results in a very different distribution in the body (enriching the liver with insulin) than when insulin is secreted
by the pancreas. We will determine the metabolic consequences of peripheral insulin delivery on liver glucose
metabolism in the HFHF dog. This will shed light on the need for ways to insulinize the liver preferentially. 2)
We will determine how the signals that regulate mealtime HGU interact with each other in HFHF fed animals
and the relative importance of the loss of insulin action and the loss of the PGS in the regulation of HGU. 3)
Like with the PGS, there are sensors in the hepatoportal region that detect when protein (amino acids) has
been consumed. The body responds to amino acids and glucose by producing insulin and glucagon, hormones
that regulate the liver's response to nutrients. While the HFHF diet causes severe hepatic glucose dysfunction,
less is known about how it affects the liver's handling of amino acids and protein metabolism. Likewise, the
interaction between liver glucose and protein metabolism in the HFHF fed liver will be examined. 4) Glucagon
has a complex role in metabolism. It counters the hypoglycemic effects of insulin (its levels increase as glucose
levels fall). On the other hand, glucagon also increases when protein is consumed. While this might be
expected to negatively impact the glucose lowering effects of insulin, recent evidence suggests that high levels
of glucagon might somehow work together with insulin to clear ingested amino acids from the blood and to
reduce glucose levels. We will determine if this is the case under more physiological circumstances. We
believe that the knowledge gained from the proposed experiments will assist in the development of new
therapeutic approaches in the treatment of metabolic disorders.

Public health relevance
Narrative Consumption of a diet high in fat and fructose is associated with a range of metabolic consequences that can lead to obesity, glucose intolerance, and diabetes, a public health crisis characterized by disability, loss of life, and great financial expense. The research described in this application seeks to understand the fundamental ways that such a diet changes the regulation of glucose metabolism, as well as the efficacy of potential treatment strategies. Our canine model is ideally positioned to act as a bridge between in vitro / small animal research and the human, allowing us to facilitate the translation of promising discoveries as well as the ability to test control mechanisms using strategies that are not possible in other species.